Precision Mapping of Knee Pain in Osteoarthritis: Understanding differences between pain with activity and rest

PROJECT ABSTRACT
This career development award focuses on training Dr. Bella Mehta (applicant) on pain phenotyping in
osteoarthritis (OA) patients and linking phenotyping data to tissue level data distinguishing between pain
experienced during activity and pain at rest. The study will enhance the goals of the Restoring Joint Health
and Function to Reduce Pain (RE-JOIN) consortium, an effort led by the NIH HEAL Initiative. The goals of
the consortium are to understand the synoviocyte-nerve interactome, which complements the focus of this
career development award. Knee OA is a prevalent condition causing chronic pain and disability, particularly
among the elderly population. Dr. Mehta has been a part of the human phenotyping working group of the
consortium and involved in meetings with pain research experts to explore precise pain phenotyping and the
utility of Quantitative Sensory Testing (QST). There is heterogeneity in patient reported knee pain knee OA
pain, with different timings, activity/rest related and anatomical distributions. Preliminary analysis from our
data suggests distinct histological patterns in bone and synovium associated with activity-limited pain versus
pain that persists at rest. The proposal aims to collect precise location and severity data of knee pain, which,
when combined with histology and magnetic resonance imaging (MRI), will help identify pathological
changes contributing to different pain types. As part of the RE-JOIN consortium we will recruit 110 patients
and add detailed pain phenotyping as a per of this career development award. Aim 1 focuses on patients
with activity-limited pain, while Aim 2 focuses on rest related pain and compares sites of knee pain with QST,
histology, and MRI changes from the medial and lateral sites. To achieve these research aims, a diverse
team of multidisciplinary experts in a variety of fields and disciplines have committed their mentorship and
support to the research endeavors and ultimately the growth of the applicant as an independent researcher.
Drs. Tuhina Neogi, Dana Orange, and Anne Marie Malfait will each contribute their extensive knowledge and
mentorship in the fields of rheumatology and underlying molecular mechanisms, with an emphasis on pain
mechanisms and osteoarthritis. Three training objectives will guide this transition to independence as a
physician-researcher. Training Objective 1 aims to attain expertise in understanding and applying various
conceptual models and methods to research focused on clinical pain assessments in OA. Training Objective
2 will drive the development of expertise in assessment and evaluation of QST, including its impact on
patient reported outcome measures. Lastly, Training Objective 3 will provide a comprehensive
understanding of histopathology in OA, including synovium, bone, and cartilage features. Mastery of QST
and clinical pain phenotyping along with histological understanding will enhance the research's impact, assist
Dr. Mehta in her growth as a pain researcher in the ﬁeld, and subsequently in dissemination of this
knowledge at the Hospital for Special Surgery, a leading institution in musculoskeletal disease.

Public health relevance
PROJECT NARRATIVE In this proposed career development supplement to the RE-JOIN consortium, we will collect paired clinical pain data that occurs with both activity and rest in knee osteoarthritis with tissue level data. To better understand mechanisms of pain – a goal that compliments that of the consortium - we will collect patient-reported pain mapping, quantitative sensory testing, and magnetic resonance imaging and link it with histopathological data from the medial and lateral knee joints of discarded tissue from knee replacement surgeries in osteoarthritis patients. Through the acquisition, analysis, and dissemination of this knowledge, we hope to make major strides in our long-term goal to improve patient outcomes for those suffering from osteoarthritis.